Dystonia Coalition- Administrative Core

ADMINISTRATIVE UNIT PROJECT SUMMARY
The main goal of the Dystonia Coalition is to facilitate collaborations that advance the pace of clinical and
translational research for isolated dystonia syndromes, previously known as “primary” dystonias. The Dystonia
Coalition includes multiple investigators at 49 different centers in North America, Europe, Israel, and Australia.
They work together with several patient advocacy groups through the Administrative Unit on 4 main Clinical
Projects, a Pilot Projects Program, and a Career Enhancement Program. The main objectives are to delineate
the phenotypic heterogeneity and natural history of the isolated dystonia syndromes, to delineate individual
temporal variations in response to current treatments, to develop objective measures for monitoring severity,
and to establish a biorepository for exploring biomarkers. The Administrative Unit will be responsible for the
overall direction and coordination of the program including coordination of its activities, ensuring effective
communication among all of its components, monitoring progress towards objectives, and maintaining a system
for fiscal accountability and resource allocation.

Public health relevance
NARRATIVE RFA TR-18-020 provides instructions that this section is not to be completed for the Administrative Unit.